Evaluating the Impact of Medical Foster Home Coordinator Effort and Experience on Costs

This project will address the HSR&D Long-Term Care and Aging priority by investigating Medical Foster
Homes (MFHs) as a community-based long-term care (LTC) alternative, and in particular compared to
Community Nursing Home (CNH) care, the primary program serving LTC needs in institutions. MFH care is
provided in private residences with trained and licensed caregivers, who live on the premises, that serve up to
three Veterans who receive VA Home Based Primary Care (HBPC) services. The need for 24 hour per day
care is increasing as the Veteran population ages. The GAO has projected that, by the year 2037, Veterans’
use of CNHs will increase 80%, and corresponding expenditures will increase approximately 150%, from a
2017 benchmark. Medical Foster Homes care is potentially less expensive for the VA. However, as the VA
considers expanding coverage of direct room & board cost of the MFH to more Veterans, the cost advantage is
unclear and understanding the implications of the MFH environment on Veteran cost and utilization becomes
more important. Across the VA, MFH programs vary in the effort and experience of the coordinators that
manage them. Although there is evidence that MFH programs cost less than CNH in the past, current
estimates are lacking, and the extent to which such cost savings is related to MFH program coordinator effort
and experience has not been established, nor is it understood whether saving is facilitated by VA patient safety
culture. To provide a cost saving alternative to institutional care, it is important to understand coordinator
impact on efficiency of operations. This project will determine the impact of dedicated coordinator effort and
experience, on overall MFH Veteran direct healthcare costs. Additionally, to be a high reliability organization,
the VA emphasizes the development of a patient safety culture among its facilities. This project will determine
whether a patient safety culture moderates the impact of coordinators on program efficiency and will inform
decisions regarding program coordinator coverage and training as impacted by patient safety culture.
Research on MFHs (see HSR&D CRE 12-029, PI Cari Levy, and subsequent publications) have shown
that VA costs and were lower among Veterans after MFH and costs were lower than Community Nursing
Homes using FY2011 data. Moreover, qualitative work has explored the role of more experienced programs.
However, there has not been quantitative research explicitly on MFH program coordinator effort and
experience in relation to cost or utilization. This project will address this gap. This project includes, in addition
to standard evaluation of expected outcomes, the evaluation of reliability of outcomes, which is expected to
improve with dedicated coordinator effort and experience guided by goals established by a patient safety
culture. The project is therefore also methodologically innovative, as it will evaluate the scale function
(representing the mean-independent variation of outcomes) in addition to the regression function. The project
has 3 aims: (1) To evaluate the VA cost and utilization of MFH Veterans and compare to (a) similar non-MFH
community-dwelling Veterans and (b) similar Veterans in CNH. (2) To evaluate the effect of coordinator effort
and experience on the VA costs and utilization for MFH Veterans and compare to similar non-MFH community-
dwelling Veterans and similar Veterans in CNH. (3) To evaluate whether the effect of coordinator effort and
experience on the VA costs and utilization for MFH Veterans is moderated by patient safety culture.
Each aim will be analyzed using fiscal years 2021 through 2023 data from the CDW, SAIL, and GECDAC
core files data sets. Data will also incorporate the monthly MFH coordinator survey, and the Patient Safety
Culture Survey. Data will include all MFH Veterans and similar non-MFH Veterans who use VA healthcare
resources. Parametric and non-parametric methods will be used for evaluation of regression and scale
functions. The primary outcome will be total VA direct costs. Secondary outcomes will include Emergency
Department visit rates and hospitalization rates.

Public health relevance
By the year 2037, Veterans’ use of Community Nursing Homes will increase 80% above 2017 levels, and corresponding expenditures will increase approximately 150%. Medical Foster Home (MFH) care is potentially less expensive. VA planning regarding MFH retention and expansion requires understanding the cost implications of MFH care. Because program coordinators are essential to MFH operations, to provide a cost saving alternative to institutional care, it is important to understand coordinator impact on efficiency of operations. This project will determine the impact of coordinator effort and experience on MFH Veteran direct healthcare costs as well as ED visits and hospitalizations. Additionally, to be a high reliability organization, the VA emphasizes the development of a patient safety culture among its facilities. This project will determine whether a patient safety culture moderates the impact of coordinators on program efficiency and will inform decisions regarding program coordinator coverage and training as impacted by patient safety culture.